Walk with Me (WWM) for Perinatal Grief

7. PROJECT SUMMARY
Pregnancy and infant loss (perinatal loss) impact approximately one in four families in the United States. Three
out of five mental health related perinatal deaths are caused by suicide. Parents who have a perinatal loss are
often not the focus of suicide prevention. Additionally, posttraumatic stress disorder is more common among
birthing people who have a perinatal loss compared to birthing people who do not. This reflects the acute,
somatic, distressing, and often disenfranchised (e.g., dismissed or ignored) experiences of bereaved parents.
Compounding the heightened distress experienced by many parents after the death of their baby, there are
few resources and those that do exist are often inconsistent and do not provide evidence-based therapeutic
content. Approximately half of Americans live in an area with a mental health professional shortage. Even
when counseling services are available, there are few providers specifically trained to support bereaved
parents. In Phase I, we developed a functional prototype of Along With Me for perinatal grief (AWM), a web-
based application that combines therapeutic content for bereaved parents and healthcare professional training.
Our clinical trial yielded moderate effect sizes for improving grief self-efficacy and reducing post-traumatic
stress avoidance symptoms. These findings were in line with our theory of change and study developed
application modules. Our successful Phase I results suggest we can confidently move to Phase II to build
additional cognitive behavioral therapy modules to support bereaved parents, tailor content for parents who
speak Spanish and those who have experienced miscarriage, complete a randomized controlled trial to
establish the evidence base for AWM, and enhance the product for adoption. Phase II development and
evaluation of the dual-language tool will allow us to create a commercially-viable product for adoption by
healthcare organizations. To accomplish this goal, we will achieve three specific aims: (Aim 1) Complete
development of an enhanced AWM application informed by the formative, usability, and outcome data
generated from Phase I, by a diverse bereaved parent community board (n = 12), and by healthcare
administrators. (Aim 2) Pilot and assess the usability of the AWM mobile app with English- and Spanish-
speaking bereaved parents (n = 20) and healthcare professionals (n = 10) and make necessary revisions.
Testing and feedback will occur in 3 waves to prepare the prototype for evaluation. (Aim 3) Conduct a clinical
trial to evaluate the efficacy, acceptability, and usability of the AWM app with 300 recently bereaved parents
randomly allocated to (a) services as usual (n = 100), (b) AWM alone (n = 100), or (c) AWM plus a peer guide
(n = 100). Our primary outcomes will be posttraumatic stress symptoms and suicidal ideation. We hope to
establish that AWM can prevent and address posttraumatic stress and suicidal ideation to improve outcomes
for bereaved parents. Without dedicated resources toward intervention, bereaved parents, especially Black,
Indigenous, and rural residing parents, will continue to have suboptimal access to evidence-based care.

Public health relevance
8. PROJECT NARRATIVE Pregnancy and early infant loss are common yet there are insufficient therapeutic resources to prevent and address the psychological complications of loss among bereaved parents including posttraumatic stress disorder and suicidality. This Phase II application proposes to expand and assess the efficacy of a promising digital therapeutic called Along With Me which combines cognitive behavioral therapy, mindfulness, informational support, normalization of grief, and healthcare professional training to provided necessary support to bereaved parents. In the present context of limited and delayed access to behavioral health resources, our mobile app will nest a flexible mobile app within healthcare settings to address significant perinatal public health challenges including preventing postpartum deaths by suicide among bereaved parents.